A cell culture management platform to improve biomedical reproducibility by combining cell line tracking, low-cost genetic analysis, and riskassessment

PROJECT SUMMARY
Irreproducibility of biomedical and preclinical research is responsible for wasting 50% of the entire research
budget and accounts for billions of wasted dollars. Issues with authenticity of key resources, such as cell lines,
form a major contributor to this problem. An alarming increase in cell authenticity issues has prompted the NIH
and some journals to take action by requiring grant applicants to discuss plans for authentication and requiring
manuscript authors to report authentication results. However, the current gold standards for cell authentication
are costly and time consuming. They present significant hurdles for researchers, leading to avoidance of testing.
Other factors that exacerbate the problem of irreproducibility include a lack of systematic reporting on
provenance details regarding passaging, maintenance protocols, chain-of-custody, and relational lineage
information. The tools available nowadays are not specifically created for cell culture and lack interoperability.
This increases the burden on reporting and reduces transparency. To address these unmet needs, FIND
Genomics is developing FIND Cell, a comprehensive cell culture management platform. The primary innovation
of this platform is the integration of three key components: 1) a collaborative, multidimensional data organization
tool for cell culture work (e.g., graphical user interface designed to facilitate tracking of cell lines across lineages),
2) risk assessment capabilities, and 3) a computational method to assess cell quality (both genetic identity and
stability) that provides users with the option of using low-coverage whole-genome sequencing. Use of our tool
will save scientists time and costs associated with ensuring cell quality. We have developed a prototype that has
been tested and graded as “Excellent” by cell experts. To bring FIND Cell to market, we aim to developing our
software as outlined in this Direct-to-Phase II SBIR project proposal: AIM 1. Benchmark our low-cost, high-
accuracy cell quality analysis through comparison with gold standards (STR typing and G-band karyotyping);
AIM 2. Develop a cell line risk assessment and decision support tool; AIM 3. Refine our management platform’s
user interface, and calculate operational savings based on user feedback. Successful completion of this project
will result in a market-ready, user-friendly platform with a validated method for cell authentication. Additionally,
our platform will include predictive risk analysis that will alert users. The early warning system, combined with
cheap and easy authentication, will reduce waste of time, effort and money on experiments with faulty cell lines.
The ease of record-keeping and -sharing in a single interface will enable transparency and rigor and improve
reproducibility in biomedical/preclinical research.

Public health relevance
PROJECT NARRATIVE The widespread cell authentication crisis directly results in billions of dollars wasted. The problem is exacerbated by the lack of transparency and reporting of lineage divergence and protocol variations. FIND Genomics is developing a comprehensive cell culture management platform that includes low-cost, low-friction genetic analysis for cell quality, and dynamic risk assessment for errors in cell lines.